Biospecimen Exchange for Neurological Disorders (BioSEND)

PROJECT SUMMARY/ABSTRACT
We have prepared this application in response to RFA-NS-20-031, which invites applicants to serve as the
NINDS Human Biospecimen and Data Repository in Neurological Disorders. The BioSpecimen Exchange for
Neurological Disorders (BioSEND) was awarded to Indiana University on September 30, 2015. This application
proposes to renew and retain BioSEND at Indiana University and expand the impact and success of BioSEND
through additional innovations and improvements.
With the transfer of the NINDS-funded biorepository to Indiana University, BioSEND dramatically expanded
the number of disorders for which samples are banked. The scope and scale of banking has also dramatically
increased with the establishment of BioSEND at Indiana University. The value of the biospecimens banked at
BioSEND is demonstrated by the substantial growth in the requests for these samples by researchers. Over the
past five years, BioSEND has made 93 distributions to 42 investigators at more than 30 institutions.
Indiana University has developed a strong biorepository team consisting of faculty with critical scientific and
leadership experience and staff with essential expertise in biobanking, clinical research coordination, and data
management. Over the past five years, we have developed a strong infrastructure and implemented a customer-
focused approach that employs innovative solutions to both specimen banking and distribution. Based on our
success in establishing a widely used biospecimen repository, we plan further improvements and expansion of
BioSEND to meet the NINDS mission to increase biobanking to support basic, translational and clinical research
in neurological disorders. We propose to pursue the following specific aims for the next five years:
Aim 1: Provide leadership to BioSEND
Aim 2: Provide study management expertise
Aim 3: Provide scientific and laboratory expertise
Aim 4: Distribute samples to approved researchers
Aim 5: Develop custom solutions to link clinical data with biospecimens

Public health relevance
PROJECT NARRATIVE This application proposes to renew and expand the NINDS Human Biospecimen and Data Repository in Neurological Disorders called the BioSpecimen Exchange for Neurological Disorders (BioSEND). Based on our success in establishing a widely used biospecimen repository, we plan further improvements and expansion of BioSEND to meet the NINDS mission to increase biobanking to support basic, translational and clinical research in neurological disorders. We propose to pursue the following specific aims for the next five years.